Midcareer Award for Research in Dementia Risk Factors and Prevention

This is a competitive renewal application for grant K24AG045334 (Midcareer Award for Research in Dementia
Risk Factors and Prevention). Consistent with PA-20-186 (Midcareer Investigator Award in Patient Oriented
Research [POR]), I propose to continue protecting 25% of my time to augment my capabilities in POR, and
provide mentoring to junior clinical investigators in the conduct of POR. The current K24 supported scientific
project and its related mentoring and training activities has leveraged grant R01AG050440 (Diabetes Status and
Brain Amyloid in Middle Aged Hispanics; PI: Luchsinger). The current K24 award proposed the examination of
plasma biomarkers of Alzheimer’s disease (AD), metabolomics, and a pilot study of tau Positron Emission
Tomography (PET), which were successfully achieved while providing mentoring and resources to several early
investigators, who have successfully obtained K and R funding. R01AG050440 will be renewed for another 5
years on 08/01/21 for another 5 years of funding, and will be leveraged again for the scientific, training, and
mentoring goals of this proposal. The new funding period will extend the ascertainment of amyloid, tau, and
neurodegeneration with brain imaging (18F-Florbetaben PET, 18F-MK6240 PET, 3T magnetic resonance
imaging [MRI]) and plasma biomarkers (Aß42/40 ratio, neurofilament light, ptau-181) for two more waves, in
addition to comprehensive cognitive testing and ascertainment of cerebrovascular disease (CVD). Preliminary
data shows that microgliosis (neuroinflammation) accompanies neurodegeneration and cognitive impairment in
diabetic (db/db) mice. Thus, I propose to train in neuroinflammation and its measurement in humans, including
plasma Glial Fibrillary Acidic Protein (GFAP) and, brain imaging (11C-ER176 PET), and apply them to the parent
study during the proposed period. The overarching hypothesis of this application is that diabetes causes
neuroinflammation that leads to neurodegeneration and associated cognitive deficits, independent of amyloid,
tau, and CVD. My primary scientific aim is to examine the association of neuroinflammation, ascertained with
plasma GFAP, with neurodegeneration, ascertained as cortical thickness on brain MRI, and memory impairment,
ascertained as total recall in the Buschke Selective Reminding Test. My first training aim 1: to train in the role of
neuroinflammation in neurodegenerative diseases and in diabetes, its measurement in plasma, and its
interpretation. My first mentoring aim is to train mentees in the primary (amyloid, tau, neurodegeneration) and
secondary constructs (cognition, CVD) of the NIA/AA research framework, and their potential relation to diabetes
and other cardiometabolic risk factors for AD/ADRD. My secondary scientific aim is to conduct a pilot study of
brain imaging with the 18kDA translocator protein (TSPO) ligand 11C-ER-176 in 20 participants in the parent
study. My second training aim is to train in the application of imaging of microglial activity and its interpretation.
My second mentoring aim is to train mentees in the importance of neuroinflammation in neurodegenerative
diseases with the assistance of the neuroinflammation experts collaborating in this proposal.

Public health relevance
Funding of this proposal will allow me to train in neuroinflammation, an important process in Alzheimer’s disease (AD) and Alzheimer’s disease related dementias (ADRD). In addition, the proposed scientific project will add the measurement of neuroinflammation to the detailed measurement of amyloid, tau, and neurodegeneration in a unique cohort of middle-aged Hispanics in New York City. This project will support mentoring of a future generation of AD/ADRD investigators.